The START trial: a proof-of-concept sedentary reduction program for prefrail older adults

PROJECT SUMMARY
Frailty is a syndromic state of vulnerability that puts adults aged ≥65 years at heightened risk of adverse health
outcomes. An estimated 50% of older Americans are prefrail—a pre-clinical stage of frailty that might be more
amenable to intervention efforts than frailty. Increasing physical activity is a promising intervention to better
manage/help reverse the multisystem dysregulation that drives frailty and sequalae. However, initiating and
maintaining habitual physical activity is difficult for sedentary older adults, particularly those encumbered by
health challenges. The 2018 US Physical Activity Guidelines recommends that all adults perform ≥150
minutes/week of physical activity and reduce sedentary behaviors. Yet, traditional approaches to increase
physical activity do little to address sedentary behavior reduction, especially for older adults. Lower sedentary
behavior is associated with improved biological and psychosocial health—independent of meeting physical
activity guidelines. Thus, there remains a critical need to implement and evaluate a structured way to reduce
sedentary behavior as a potential pathway for habitual physical activity engagement. Using novel objectively
measured physical activity metrics, our research group has shown that daily sedentary time, either in total or
accrued in a prolonged manner, is associated with frailty. Our observation evidence shows that: 1) daily, non-
exercise physical activity declines and becomes more fragmented with age (less continuous activity with longer
sedentary bouts), 2) higher daily sedentary time and activity fragmentation are both associated with higher
frailty incidence, and 3) sedentary time is positively associated with frailty-related markers of inflammation. We
propose a pilot study in which we randomize 60 prefrail community-dwelling older adults to receive one of two
interventions, each designed to gradually reduce sedentary time: 1) continuously to form a 30-minute walking
bout, or 2) in a bouted manner to form three 10-minute walking bouts. Project goals are to: a) explore the
effectiveness within and between interventions to decrease objectively measured sedentary time over 2
months; b) assess decreased sedentary time’s association with i) patient-reported outcomes and ii) frailty-
related inflammatory markers. The primary outcome is accelerometer-determined sedentary time. Secondary
outcomes include activity fragmentation, patient-reported outcomes, and inflammatory markers. With a
transdisciplinary mentoring panel, my career development plan builds on my expertise in aging and physical
activity epidemiology to gain proficiency in: 1) developing and implementing clinical trials for older adults, 2)
designing interventions to improve health behaviors, 3) conducting frailty and inflammation related research
and 4) gaining competencies to become an effective PI and leader. This project utilizes the infrastructure of the
Johns Hopkins Institute for Clinical and Translational Research (ICTR) and Beacham Center for Geriatric
Medicine which have strong records of supporting early-stage faculty. This award will facilitate my transition to
an independent investigator and will also provide informative data for R21 and R01 applications.

Public health relevance
PROJECT NARRATIVE The rapid expansion of the US older adult population highlights the public health importance of preventing frailty—an age-related syndromic state of vulnerability and heightened risk of adverse health outcomes. Increasing physical activity is a promising intervention to prevent frailty but initiating and maintaining habitual physical activity is difficult for older adults, particularly those encumbered by health challenges. This project aims to test and compare novel, remotely deployable strategies to reduce daily sedentary time among inactive, prefrail older adults as a first step to form long-lasting physical activity habits and combat frailty.